Mechanisms of extrahepatic biliary proliferation and regeneration

PROJECT SUMMARY/ABSTRACT
This application seeks an administrative supplement for the ongoing NIDDK K08 funded project. This support
will assure completion of the proposed research project with new, complimentary state-of-the-art approaches
and facilitate the PI’s transition to the next career stage, an independent NIH-funded investigator. The
Supplement will provide needed funds to support progress during the PI’s critical life events, childbirth and
primary caregiving responsibilities for her mother. The research project is focused on cholangiopathies, which
are incurable, progressive extrahepatic bile duct (EHBD) disorders characterized by injury-induced
inflammation and cholangiocyte hyperproliferation. Development of therapies for cholangiopathies requires a
better understanding of cellular and molecular mechanisms regulating EHBD proliferation during homeostasis
and in response to injury. This supplement and the parent application aim to answer fundamental questions
about the mechanisms of EHBD regeneration and explore strategies to modulate biliary proliferation. The
rationale for the proposed research is that defining cellular and molecular crosstalk underlying cholangiocyte
responses to injury can inform novel therapeutic strategies for cholangiopathies and hepatobiliary regenerative
medicine. Our findings to date suggest that Hedgehog (HH) and WNT signaling play important roles in EHBD
homeostasis and response to injury. Increased cholangiocyte proliferation after acute injury is associated with
an upregulation of cholangiocyte HH ligand expression, which induces stromal cell expression of CXCL1. The
CXCL1 cytokine, in turn, recruits neutrophils to the injured tissue to promote biliary proliferation. Additionally,
EHBD injury results in WNT signaling upregulation in vivo, and the WNT pathway amplifier, RSPO, is required
for EHBD organoid proliferation in vitro. The overarching hypothesis for this and the parent proposal is that HH
and WNT signaling regulate crosstalk between epithelial and stromal cells to promote EHBD
proliferation after injury. In this proposal I will use wild type and genetic reporter mice to study EHBD cell
populations. Bile duct ligation will be used as an injury model. I will examine EHBD cell expression profiles at
homeostasis and after injury using single cell and bulk RNA sequencing approaches. These studies will help to
(1) determine if GLI1+ HH-responsive cells are fibroblasts expressing Cxcl1; (2) determine if GLI1+ cells are a
source of RSPO; and (3) gain insight in obstructive injury-induced expression profiles of epithelial, stromal, and
immune cell populations in EHBDs. These experiments are directly pertinent to Aims 1 and 2 of the parent
proposal and will increase impact of the K08 project results. Importantly, they will also generate preliminary
data for a successful R01 application. Ultimately, the Supplement will allow the PI to step up momentum and
promote her transition into an independent NIH-funded investigator and support her long-term goal to
understand fundamental mechanisms of EHBD biology to ultimately improve outcomes in patients with
cholangiopathies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because cholangiopathies, which often affect extrahepatic bile ducts, are poorly understood, and therefore have no effective treatment options. This project will unveil cellular and molecular mechanisms underlying extrahepatic bile duct responses to injury and inform potential strategies for treatment of cholangiopathies and prevention of their complications. Thus, the proposed research is relevant to the NIH mission that pertains to improvement of people’s health and quality of life.